A Genetic Dissection of the Incomplete Penetrance of RPSA Variants for Isolated Congenital Asplenia

PROJECT SUMMARY/ABSTRACT
Isolated congenital asplenia (ICA) is characterized by the absence of a spleen at birth without any detectable
associated developmental abnormalities (OMIM #271400). It is a life-threatening disorder, as affected patients
are prone to invasive bacterial disease, especially prior to the diagnosis of ICA. We previously discovered
germline heterozygous variants in the coding region and 5'UTR of RPSA (encoding ribosomal protein SA) as the
first genetic etiology of ICA, and demonstrated that RPSA haploinsufficiency underlies autosomal dominant
ICA. Follow-up analysis of the splenic relatives of ICA patients in our cohort revealed that some coding RPSA
variants and all 5'UTR RPSA variants display incomplete penetrance for ICA. We now hypothesize that
sufficiently high levels of wild-type (WT) RPSA expression may compensate for deleterious RPSA variants, and
that variation in WT RPSA expression between individuals underlies the observed incomplete penetrance.
Furthermore, we hypothesize that variants in the 5'UTR of RPSA impair, but do not ablate, the translation of
RPSA mRNA, thereby lowering the threshold of WT RPSA expression required to compensate and explaining
why the observed 5'UTR variants all lead to ICA with incomplete penetrance. To test our hypothesis, we will
first assess the impact of the 5'UTR variants on RPSA translation using ribosome-profiling, polysome analyses,
and mRNA secondary structure probing and mutagenesis experiments. We will then search for sequence
variation between the splenic and asplenic members of our cohort at genetic positions that modulate the
expression of WT RPSA. Finally, we will develop assays to precisely quantify the allele specific expression of
RPSA mRNA and then compare WT RPSA mRNA expression between splenic and asplenic carriers of
deleterious RPSA variants. We have already sequenced the whole genome of 69 RPSA heterozygotes in our
cohort. Our preliminary data are exciting, as we have delineated three haplotypes at the WT RPSA locus that
seem to tightly correlate with the presence or absence of a spleen in individuals heterozygous for a variant RPSA
allele. An understanding of why some RPSA genotypes lead to ICA with incomplete penetrance will prove
useful in our understanding of a life-threatening immunodeficiency, and will provide a roadmap for the study
of incomplete penetrance in other genetic diseases driven by haploinsufficiency.
I am an MD/PhD student at the Weill Cornell/Memorial Sloan Kettering/Rockefeller Tri-Institutional Program,
performing the proposed research in the laboratory of Dr. Jean-Laurent Casanova at The Rockefeller University.
My long-term goal is to become a physician scientist who balances patient care with running an independent
research program at an academic institution. The plan outlined in this proposal, along with the support and
mentorship provided by Dr. Casanova, Dr. Boisson, my thesis research committee, and the Tri-Institutional
administrative faculty will help me achieve my career goals.

Public health relevance
PROJECT NARRATIVE Inherited RPSA haploinsufficiency, underlain by both coding-sequence and 5'UTR variants in RPSA, is the first known genetic etiology of ICA. As is frequently observed in genetic diseases driven by haploinsufficiency, the penetrance of some coding RPSA variants and all 5'UTR RPSA variants for ICA is incomplete. We propose to investigate the mechanism by which 5'UTR variants impair RPSA protein production, and to search for genetic etiologies of the incomplete penetrance of ICA.